Epicardial regulation of cardiomyocyte function via modulation of extracellular signals: toward a model of human muscle pump function

Project Abstract
N/A per PA-21-071 and additional NHLBI instructions.

Public health relevance
Project Narrative N/A per PA-21-071 and additional NHLBI instructions.